Sustained eIF5A hypusination at the core of brain metabolic dysfunction in TDP-43 proteinopathies

PROJECT SUMMARY/ ABSTRACT
TAR DNA-binding protein 43 (TDP-43) pathology is associated with clinical dementia and occurs in more
than half of clinically diagnosed Alzheimer’s disease (AD) patients (1, 2). The discovery of limbic-predominant
TDP-43 encephalopathy (LATE) emphasized the importance of age-related TDP-43 proteinopathy, with or
without co-morbid AD pathological hallmarks. The lack of disease-modifying agents against TDP-43 pathology
creates an urgent need to identify novel therapeutic pathways against TDP-43 proteinopathy. Interestingly,
regional disruption of glucose uptake and utilization is linked to the progression of AD neuropathology (3-5), and
yet, there is no consensus on the effect of TDP-43 on glucose and energy homeostasis in the diseased brain (6).
This proposal will address this significant gap in knowledge by studying the impact of the eIF5A hypusination
pathway on the brain’s metabolic state in TDP-43 pathology. eIF5A is an initiation/elongation factor and the only
protein undergoing hypusination (eIF5AHyp). Deoxyhypusine synthase (DHS) and deoxyhypusine hydroxylase
(DOHH) activity convert a single lysine to a hypusine moiety. Our feasibility data finds that TDP-43 pathology in
AD brain and TDP-43 mouse models induces DHS expression and hypusine levels. Additionally, we show that
enhanced hypusination exacerbates TDP-43 pathology, dysregulates brain glucose homeostasis and exerts
mitochondrial bioenergetic defects. Our central hypothesis states that DHS-targeted strategies reducing
hypusine levels will ameliorate TDP-43 neuropathogenesis by restoring brain glucose metabolism and
mitochondrial bioenergetics, upstream of cognitive decline and neurodegeneration. In Aim 1, we will
establish how conditional deletion of the DHS (DHSko) in the adult forebrain of the TDP-43 transgenic mouse
model will affect the brain metabolic transcriptomic profile via NanoString analysis and determine biological
signatures that define the eIF5AHyp - TDP-43 phenotype. We will also utilize the CNS-Met Metabolomics Core to
measure brain metabolite levels, while biochemically determining metabolic proteins, enzymes, and TDP-43
pathology. We will further elucidate how DHSko can rescue LTP, cognitive performance, and neurodegeneration
associated with TDP-43 phenotype of a novel TDP-43 animal model. In Aim 2, we will define the role of eIF5AHyp
on the mitochondrial bioenergetics of neurons and astrocytic-responsive neurons. We will establish how DHS
inhibition rescues mitochondrial bioenergetics and restores metabolite balance in primary cells. We will also
determine the cellular and mitochondrial TDP-43 accumulation and mitochondrial structure integrity. Overall, the
proposed studies will provide evidence that the eIF5AHyp pathway in the TDP-43 phenotype is upstream of
irreversible stages of dementia. It also offers the first detailed mechanisms of how reducing hypusine restores
glucose dysregulation and mitochondrial dysfunction, maintaining neuro-astrocytic support and healthy neuronal
activity, while rescuing the pathological phenotype in animal models of TDP-43 proteinopathy.